TweenVax: A comprehensive practice-, provider-, and parent/patient-level intervention to improve adolescent HPV vaccination.

PROJECT SUMMARY/ABSTRACT
Persistent human papillomavirus (HPV) infection is responsible for over 30,000 new cases of cancer annually
in the United States (US). HPV infection can be prevented by immunization, but 12 years after being
recommended for use, HPV immunization rates among US adolescents remain suboptimal. While uptake of
other vaccines recommended for 11-12 year-olds is at or near 90%, only 43% of adolescent boys and girls are
up-to-date for HPV vaccination. Prior efforts to improve HPV vaccine uptake have followed standard best
practices for immunization programs, including education provision for parents and adolescent patients, and
Health Belief Model-inspired appeals to disease severity. One key barrier to improving HPV vaccine uptake is
that healthcare providers often do not recommend this vaccine with the same strength as they do for other
adolescent vaccines. Continued low uptake of HPV vaccine indicates that new systems-level approaches,
beyond standard public health education campaigns, are needed. These systems-level approaches –
incorporating the healthcare practice and provider as well as the patient - must be designed and packaged in a
way to address the quality of, and context around, provider recommendations.
Our research team has developed and pilot-tested an intervention package – TweenVax – designed to improve
HPV vaccine uptake at the practice-, provider-, and patient/parent-level. Evaluation of TweenVax identified key
elements for expansion to improve the provision and strength of provider recommendations. Gaps remain in
terms of how best to address missing or substandard provider recommendations, including addressing
moment-to-moment patient and data flow and various points of intervention during the clinic visit including desk
check-in through clinical examination and vaccination and follow-up appointment scheduling. Enhancements to
the TweenVax intervention will include improvements in practice-level communication in the context of patient
flow and additional training for non-clinical staff, development of enhanced training modules for clinical staff,
including interactive experiential training and provision of continuing education credits, and updates to the
content and presentation of the TweenVax tablet- and web-based educational program.
The proposed multi-phase study will 1) assess, using ethnographic observations and in-depth interviews, both
best practices and deficiencies in all clinical aspects of the adolescent healthcare encounter, with findings used
to refine existing intervention tools to improve HPV vaccination of 9-12 year-olds; and 2) evaluate the efficacy
of our comprehensive intervention in improving HPV vaccine uptake among 9-12 year-old girls and boys in
Georgia and Tennessee. This assessment, through a three-arm trial, will provide the opportunity to assess the
efficacy of the intervention package as a whole, as well as to determine the efficacy of individual components
(e.g. practice-/provider-level components independent of patient/parent-level components).

Public health relevance
PROJECT NARRATIVE Suboptimal human papillomavirus (HPV) vaccine uptake has been an intractable problem since it was recommended for use in the US 12 years ago. Continued low uptake of HPV vaccine indicates that new systems-level approaches, beyond standard public health education campaigns, are needed to improve provider’s recommendations for HPV vaccination. We will utilize formative research to improve our existing TweenVax intervention, leading to an evaluation to assess the efficacy of the practice-, provider-, and patient/parent-level intervention package in improving HPV vaccine recommendations and uptake.